Medical Scientist Training Program

PROJECT SUMMARY/ABSTRACT
The Emory Medical Scientist Training Program leverages our institution’s comprehensive academic programs
and diverse clinical training sites to create unique, interdisciplinary training opportunities that culminate in the
award of the dual MD/PhD degree. Under the Director’s lead, Co-Directors focus on clinical and research
phases of training. Significant clinical exposure precedes graduate training to (a) ensure alignment of clinical
and research objectives and (b) facilitate the transition to research-intensive residencies and lifelong careers
as physician scientist. Training begins with thirty months of medical training (12 months of which consist of
required clinical rotations), during which students also participate in a journal club, advising activities and
research rotations that culminate in selecting a PhD advisor and program. During the PhD years, the MD/PhD
Program tracks milestones (preliminary exams, formation of dissertation committee, completion of training in
research ethics and reproducibility of research; publication requirements; re-entry timeline) to ensure
consistent, rigorous training across all PhD paths. The MD/PhD Program also incorporates mentor-mentee
check-ins several times a year to ensure supportive training environments and interventions as needed to
ensure timely progress to degree. Protected time for longitudinal clinical experiences clinical continuity during
the PhD; a smooth post-PhD transition to the final year of clinical training is managed through Re-Entry
Course. Emory University’s collaborative ethos is reflected in our program’s academic and administrative
structures. The MD/PhD Program is sited within the School of Medicine Office of Medical Education and
Student Affairs suite for prompt access to our Registrar, Financial Aid and wellness/support offices such as the
Office of Multicultural Affairs. Our monthly Clinical Research Conference offers opportunities for presentations
and professional development activities. Our Laney Graduate School partnership ensures smooth transitions
between the medical and graduate phases and affords training in the Division of Biological and Biomedical
Sciences, the Biomedical Engineering Program (joint program Department of Biomedical Engineering of
Georgia Tech and Emory), in any of the doctoral programs in the Rollins School of Public Health, or in
graduate programs of Emory College (e.g., Anthropology, Chemistry, Psychology, Sociology). An Executive
Committee (which includes partners from our participating schools and programs as well as student leadership
representatives) provides oversight. Our Admissions Committee (which includes student representatives)
embraces holistic application review. Our annual two-day Retreat provides an opportunity for socializing and
reflection on program goals and future directions A grant-writing course taught by one of our program Co-
Directors helps trainees prepare NRSA and other fellowship applications. Our students partner with program
faculty and staff to spearhead new initiatives, participate in recruitment activities, curriculum development, and
program evaluation, all of which leads to program cohesion and physician scientist leadership development.

Public health relevance
Project Narrative Emory prepares physician scientists to tackle health promotion, disease treatment and the pursuit of research- intensive careers. We offer research training in the biomedical sciences, biomedical engineering (Emory/GA Tech joint program), public health and social sciences (such as anthropology and sociology) to diversify the physician scientist training force and enhance early appreciation of the power of multidisciplinary approaches. Clinical training across multiple sites that include Grady Memorial (level I trauma/safety net hospital), Emory University Hospital Midtown (urban community hospital), the Atlanta VA Medical Center (serving Veterans across northeast GA), Wesley Woods (geriatric hospital), and Children’s Healthcare of Atlanta cultivates appreciation for the specific needs of diverse patient populations.